Characterizing Ahcy as a redox regulated enzyme in the Drosophila eye under oxidative stress

Project Summary
Oxidative stress contributes to the development and progression of ocular diseases including cataracts,
glaucoma, age-related macular degeneration, and diabetic retinopathy. One carbon metabolism influences the
response to oxidative stress via antioxidant biosynthesis; however, this pathway is also perturbed upon oxidative
stress in the Drosophila eye. One explanation for the observed dysregulation of one carbon metabolism under
oxidative stress is because of oxidative modifications on the key enzyme, Adenosylhomocysteinase (Ahcy). Ahcy
is a highly conserved enzyme and is solely responsible for the hydrolysis of S-adenosylhomocysteine (SAH) into
adenosine and homocysteine in all higher eukaryotes. Upon inducing oxidative stress in Drosophila cells and
eyes, Ahcy becomes oxidized at cysteine residue 195 (C195) correlating with increased SAH. This is important
because increases in SAH can inhibit methylation reactions and alter the epigenome; however, the mechanism
by which oxidative stress perturbs one carbon metabolism is unknown. Based on these data, I hypothesize that
redox modifications at C195 inhibit Ahcy activity under oxidative stress leading to increased SAH and a
decreased methylation capacity resulting in changes in gene expression. In the proposed studies, I will employ
in vitro assays, biochemical, genome-wide sequencing, and genetic manipulation studies to elucidate if Ahcy is
redox regulated and if it serves as a neuroprotective mechanism against retinal degeneration. In aim I, I will
determine if C195 is the only (or major) oxidized cysteine, determine the type of oxidative modification,
characterize the impact of C195 oxidation on enzymatic activity of Ahcy using a novel DESI-MS approach, and
test if C195 mutations regulate Ahcy enzymatic function in vivo. In aim II, I will identify genes regulated by Ahcy,
test if the genetic downregulation of Ahcy alleviates blue light induced retinal damage, and identify the genomic
loci directly bound by Ahcy. Along with the experiments planned in these aims, I will obtain expertise in
recombinant protein purification, enzymatic assay development and characterization, and proficiency in large-
scale dataset bioinformatic analyses. These skillsets will be an asset for my future career goal of entering the
pharmaceutical industry. Overall, this proposal will elucidate the regulation mechanism of Ahcy and may lay the
foundation for future studies to develop targeted therapies to delay or prevent the onset ocular disease.

Public health relevance
Narrative Oxidative stress contributes to the development and progression of ocular diseases including cataracts, glaucoma, age-related macular degeneration, and diabetic retinopathy. One-carbon metabolism influences the response to oxidative stress via antioxidant biosynthesis; however, this pathway is also perturbed by oxidative stress in the eye. In these studies, I propose that oxidative stress leads to the oxidation of Adenosylhomocysteinase (Ahcy) inhibiting its activity, resulting in increased SAH and decreased methylation capacity.